Risk Factors for Chronic Memory Problems after Traumatic Brain Injury

Traumatic brain injury (TBI) is a major health problem among US military service members and Veterans.
Although many with mild TBI will recover within 1-2 weeks, those with moderate to severe TBI as well as nearly
50% of those with mild TBI will have persistent symptoms lasting for months. Understanding the risk factors
involved in the persistent sequelae after TBI and the underlying molecular mechanisms will facilitate the
development of novel therapeutics. One potential factor recently identified in a study of US military service
members is pre-exposure to early stressful life experiences. Adverse childhood experiences are reported at
significantly higher levels among military personnel and Veterans than civilians. A key mechanism linking chronic
stress in early life to neurological problems in adulthood is immune dysregulation. Exposure to early life stress
(ELS) enhances pro-inflammatory cytokine release by microglia in response to a subsequent inflammatory
challenge. The goal of this proposal is to determine if ELS during development limits the recovery trajectory after
a TBI that occurs in adulthood. Using brief daily maternal separation in rat pups to model ELS, we have found
that ELS prior to TBI in adulthood increased interleukin-1β (IL-1β) levels and expression of the NLRP3
inflammasome, which is a multi-protein complex that results in cleavage and activation of IL-1β. Exposure of
ELS prior to TBI also resulted in hippocampal atrophy, neuronal loss, and hippocampal-dependent learning
deficits. In contrast, TBI alone without stress or ELS in non-injured animals did not increase IL-1β levels, nor
were there observable learning deficits or pathology within the hippocampus. Treatment with an NLRP3
inflammasome inhibitor reversed these learning deficits and reduced hippocampal pathology and pro-
inflammatory cytokine expression. In this proposal, we will test the hypothesis that ELS limits the recovery after
TBI by increasing inflammatory signaling in microglia through the NLRP3 inflammasome, leading to the
worsening of hippocampal pathology and the development of persistent learning and memory deficits. To test
this hypothesis, the following aims are proposed: 1) To determine if ELS prior to TBI experienced in adulthood
increases microglia activation, potentiates pro-inflammatory cytokine expression and activates the NLRP3
inflammasome, 2) To determine if ELS and TBI result in chronic behavioral problems and if these behavioral
deficits can be improved with an NLRP3 inflammasome inhibitor, and 3) To determine if ELS exacerbates
hippocampal neuronal and synaptic loss after TBI and if this can be reduced with an NLRP3 inflammasome
inhibitor. These studies will determine whether stress in early childhood is a predisposing factor for the
development of persistent neurological sequela after TBI. We will also test a promising therapeutic approach for
TBI, an NLRP3 inflammasome inhibitor, to determine if this will reduce inflammation, prevent hippocampal
pathology and improve learning and memory after ELS and TBI.

Public health relevance
Reports of adverse experiences in childhood are highly prevalent among US military personnel and Veterans. Chronic stress in early childhood alters the immune system and increases inflammation in response to challenges in adulthood. In this proposal, we will determine if chronic stress in early childhood is a risk factor for persistent symptoms after mild traumatic brain injury TBI. Although the majority of TBIs in US military personnel and Veterans are mild, and recovery occurs in most mild TBI patients after 1-2 weeks, a subset have persistent symptoms such as cognitive problems lasting for weeks to months. This proposal will determine if a history of chronic stress in early childhood limits the recovery trajectory after a TBI that occurs in adulthood. We will identify the underlying molecular mechanisms that are initiated by chronic childhood stress to result in worsened outcome after TBI. We will also test a therapeutic that will target these molecular mechanisms and determine if this therapeutic improves behavioral recovery in the chronic phase of TBI.